University of Michigan Vision Research Center

SUMMARY/ABSTRACT - OVERALL
Continued support is sought for the University of Michigan Vision Research Center (UMVRC), previously called
the Core Grant for Vision Research at the University of Michigan. Support for five Cores is requested: 1) a
Data Integrity Core designed to provide increased rigor to human and animal studies, staffed by a statistician;
2) a Functional Assessment Core for the imaging of ocular structures and the evaluation of ocular function in
living laboratory animals, staffed by an animal technician; 3) an Instrument and Electronics Service Core for
designing and constructing mechanical instrumentation and associated electronic equipment and modifying or
repairing existing instrumentation and electronics, staffed by an instrument maker and electronics engineer; 4)
a Molecular Biology Core for providing access to instrumentation necessary for molecular biology and a facility
for stem cell biology, staffed by laboratory technicians; and 5) a Morphology and Imaging Core for providing
access to state-of-the-art equipment and expert personnel for ocular tissue processing and microscopy
including light, wide-field and confocal fluorescence microscopy, and image analysis, staffed by a technician.
The specific aims of the UMVRC at the University of Michigan are to enhance the research environment for
vision scientists, facilitate collaborative studies of the visual system and its diseases, and expand vision
research on this campus to bring the skills and perspectives of non-vision scientists to bear upon research on
the visual system to achieve our goal of improving patient’s lives by curing, treating and preventing eye
disease.
The 29 participating investigators currently hold 10 active NEI R01 grants. The research interests of these
investigators are diverse and include electrophysiology, neurobiology, biochemistry, molecular biology,
molecular genetics, developmental biology, biostatistics, immunology, and clinical ophthalmology. The UMVRC
is housed within the W.K. Kellogg Eye Center, a 300,000 sq. ft. building complex containing space dedicated to
each of the Cores, plus state-of-the-art facilities for basic and clinical research. The Department of
Ophthalmology and Visual Sciences and the University of Michigan provide substantial additional resources
that support the shared goal of fostering vision research.

Public health relevance
NARRATIVE – OVERALL The University of Michigan Vision Research Center provides state-of-the-art equipment and technical expertise and service for scientists at the University of Michigan to advance research programs into understanding the visual system and to develop novel therapies to treat blinding eye disease and improve the visual health of the country.